Mentored Experience to Expand Opportunities in Research version 3 (METEOR v. 3)

The importance of science, technology, engineering, and math (STEM) to our daily lives has been
heightened by the nature of the pandemic: from vaccines to computer programs that allow us to
stay connected, the innovations that are integral to our daily lives are based in STEM. Further, as
healthcare researchers, we recognize that the brain underpins the nature of the human
experience and is involved with a wide variety of healthcare topics beyond the brain/spinal cord,
including but not limited to oncology, trauma, sleep, hearing and speech, neurodevelopmental
disabilities and general health/safety. Understanding how the nervous system interrelates with
various STEM concepts, impacts neurodevelopment, and influences health outcomes is critical
for building a capable workforce. The lack of career pathways for capable young innovators in
brain-based STEM and health backgrounds signals a continued need for a focus on STEM
literacy and competencies throughout K-12 education. Mentored Experiences to Expand
Opportunities in Research version 3 (“METEOR v. 3”) will provide meaningful experiences for
Washington, DC metro area high school students and STEM teachers-in-training with a specific
focus on understanding the healthy and diseased brain, spinal cord, and peripheral nerves
through a children’s health lens. METEOR v. 3 will engage participants in inquiry-based
biomedical, behavioral, and clinical research in the setting of Children’s National Hospital and its’
Research Institute. We will provide a comprehensive program and curriculum, which will employ
unique, research-based educational practices designed to stimulate interest and advance
knowledge in neurosciences, neurobiology, behavioral health and related fields. These innovative
hands-on experiences will stimulate the next generation of students and teachers to bring
neurosciences to the forefront of STEM and health care research

Public health relevance
To bring neurosciences to the forefront of STEM and health care research, Mentored Experiences to Expand Opportunities in Research version 3 (“METEOR v. 3”) will provide handson research experiences for high school students and STEM teachers-in-training during the summer academic break with continued activities through the school year. METEOR v. 3 will immerse Washington, DC metro area high schoolers and future STEM teachers into inquirybased biomedical, behavioral, and clinical research at Children’s National Hospital and its Research Institute. With a comprehensive mentorship program and core curriculum, METEOR v. 3 will employ unique, research-based educational practices designed to stimulate interest and advance knowledge in the neurosciences, neurobiology, and related fields.